A Mobile Health Application to Detect Absence Seizures using Hyperventilation and Eye-Movement Recordings

Research Strategy
1. Executive Summary of Predicate SBIR Phase I Grant and Team
The overall goal of our predicate SBIR Phase I grant is to validate the Eysz mobile health (mHealth) application
and develop algorithms to diagnose and monitor childhood absence epilepsy (CAE) in the clinical setting.
Eysz, Inc. is developing a mobile health (mHealth) application and algorithms to remotely diagnose and
monitor CAE to improve outcomes. Currently, absence seizures are challenging to identify,leading to diagnostic
delays and difficulty measuring treatment efficacy. Untreated seizures place children at risk for accidental injury
and learning loss. The gold standard for seizure detection is video EEG (VEEG), but it is expensive, limited to
clinical settings, and hard to access. As a result, clinicians rely on self-reports, despite studies showing
patients report only 6% of all absence seizures, and caregivers report only 14%. Even primary care providers
have difficulty identifying absence seizures and rely on VEEG, referring 5 patients for every 1 diagnosed. Once
diagnosed with CAE, children are started on anti-seizure medications (ASM), which result in seizure freedom in
less than 60% of children. However, no new treatments have been approved since the 1990s, partially due to
difficulty measuring seizures.4 Other strategies to monitor seizures, such as ambulatory EEG, lack the
sensitivity and specificity of VEEG, and can add to the stigma of people with epilepsy. Thus, there is a
critical need for a remote diagnostic/monitoring tool for absence seizures.
The aim of the SBIR proposal is to test and further develop an mHealth app that uses (1) supervised guided
hyperventilation (HV), with (2) eye movement and facial biometric data to monitor seizure susceptibility and
treatment responses in CAE. Achieving these goals will decrease costs of care, morbidity, and mortality and
improve quality of life for those with childhood absence epilepsy.
CAE is the most common pediatric epilepsy syndrome, affecting 10–17% of all children with epilepsy. Seizures
occur many times daily and consist of brief losses of consciousness (LOC), with immediate return to baseline
awareness and activity. Seizures typically manifest as staring spells, sometimes with rhythmic eye blinking or
motor automatisms. As LOC may occur at any time without warning, absence seizures have a significant
impact on quality of life (QOL), and accidental injury is common, with 20% of young adults—3% per
year—suffering an injury during a seizure. The clinical course of CAE is variable, and remission rates are far
lower than in other idiopathic epilepsies. In five prospective cohort studies, only 57–74% achieved seizure
freedom. Thus, there is a critical need for new therapeutics for absence epilepsy and better tools for monitoring
therapeutic responses.
The current standard of care for measuring treatment outcomes is self-reported data. Large-scale clinical trials,
including those testing new antiseizure medications, population-based assessments, and other epidemiological
studies also use self-reporting to determine optimal therapy regimens. Critically, however, multiple clinical
studies show patient seizure counts provide inaccurate information. Patients report only 6% of all experienced
absence seizures, whereas caregivers report only 14%. In a recent study examining self-documentation of
absence seizures by adults with idiopathic generalized epilepsy, inaccurate seizure counts were found to
substantially impact outpatient management and treatment.
The gold standard for detecting and characterizing seizure activity is a neurologist reading of a VEEG. In the
home setting, where > 99% of seizures occur, VEEG is not readily available because of poor patient
acceptability, poor detection capability, high cost and continued reliance on asynchronous review. The FDA
has approved two non-EEG-based devices to detect convulsive seizures, but these are responsible for only <
25% of all seizure activity. To address this significant unmet market need, Eysz is developing an mHealth app
and accompanying algorithms to improve diagnosis and monitoring of CAE. The mHealth app standardizes the
approach for administering and quantitating the effectiveness of HV-induced seizures. The app uses
animations and interactive graphics to guide users through HV while capturing audiovisual data. Eye
movements, facial biometrics, number and length of exhales, and other associated data will be used to
measure the effectiveness of HV to detect HV-induced seizure activity, providing an affordable and accessible
tool to reliably monitor absence seizures. This initial grant focuses on an in-clinic release with additional work
needed prior to the release of the device in a home setting.
This proposal focuses on developing algorithms for analysis of video quality, effectiveness of HV, and seizure
identification using a smartphone-based guided HV app. The Specific Aims are:
Aim 1: Collect data from the Eysz mHealth app concurrently with VEEG and assess usability.
Aim 2: Evaluate the potential for a new “gold standard” metric for algorithm validation. Evaluate if the
the majority of 3 epileptologists reading the video produced by the Eysz mHealth app identify absence seizures
with >80% sensitivity and specificity compared with the majority agreement of 3 independent epileptologists
reviewing VEEG.
Aim 3. Develop ML methods that use facial biometrics and eye tracking data to quantitate seizures.
Our proposed I-Corp team will include the following 3 members, who are committed to the time requirements of
the program.
Member Name Role
Rachel Kuperman, MD PI/PD
Parth Amin C-Level Corporate Officer (COO)
Tracey Fisher Industry Expert
2. I-Corps team and Project Plan
The aim of our predicate SBIR Phase I grant is to validate that a clinician read of the video from the Eysz
mHealth App is equivalent to video EEG read and develop AI based algorithm for seizure identification.
Achieving these aims will signal successful completion of Phase I and our readiness to transition to Phase II.
The learnings from the Phase I grant will be incorporated into the app to improve usability and allow for the
App to be tested in the home environment, and validate our seizure detection algorithm as we work towards
FDA clearance and commercialization readiness.
The Eysz team participated in the NIH I-Corp program during our previous SBIR phase 1 grant. While the
results of the SBIR were technically successful, the data collected during the I-Corp program informed our
decision to pivot from a continuous use wearable eye tracking glass to an intermittent usage smartphone
based app to better meet the customer and market needs. Given the significant pivot, our goal with this NIH
I-Corp is to work towards commercial readiness by refining our business model including: reimbursement
strategy, business/pricing models, and understanding the purchasing process as we work towards FDA
clearance.
Our proposed I-Corps team will include the following 3 members.
Member Name Role
Rachel Kuperman, MD PI/PD
Parth Amin C-Level Corporate Officer
Tracey Fisher Industry Expert
The team, which has been collaborating since February 2020, has demonstrated expertise in clinical research,
product development, and commercialization. The following is a summary of their expertise:
Rachel Kuperman, MD (PI/PD) leads the management team and clinical research. Rachel is a neurologist with
dual certification in epilepsy and neurology and has over 10 years’ experience directing the clinical epilepsy
and research programs at UCSF Benioff Children’s Hospital, Oakland. She is also the inventor of the core
technology and has a strong background in clinical research, having served as the PI on multiple clinical trials,
including being the PI for multiple SBIR Phase I grants. Her undergraduate degree in physics from UCSD, and
her neurology and neurophysiology training at Columbia and UCSF, have helped her bridge the
clinical/computational divide. Early in her career, Dr. Kuperman was identified as a leader at Children’s
Hospital, where she was invited to participate in the UCSF Physician Leadership Program in 2011. Dr.
Kuperman was awarded $80K in grants from UCSF, including the Junior Investigator Award for research,
towards development of her patent. She was recognized by the Epilepsy Foundation of Northern California
with the Volunteer of the Year award in 2016. Dr. Kuperman was a Fall 2018 Fellow at UC Berkeley Law Form
and Fund, which focuses on the core legal, financial, and organizational aspects of starting and scaling a
business. She has since received the Ferolyn Fellowship award from the Fogarty Institute for Innovation,
which provides mentoring to rising medtech leaders with a passion to transform healthcare.
Parth Amin, our Chief Operating Officer, brings 20 years of medical device experience, including having
worked for global healthcare companies such as Siemens Healthineers, Varian Medical Systems, and
Omnicell. He has held a variety of pivotal roles in the areas of product management, program management,
and alliance management while successfully attaining objectives related to innovation, product development,
revenue, and market share growth. His expertise in product development and alliances, with an emphasis on
go-to-market strategies involving partnered solutions, has allowed us to start identifying and establishing key
technology, clinical, and commercial partners, who in turn will enable us to translate this meaningful innovation
into a commercially viable product. As part of 3-2 Dual Degree Program, Mr. Amin holds a BE in Electrical
Engineering from Washington University and B.S in Pre-Engineering from Birmingham-Southern College.
Tracey Fisher is an accomplished business executive with over 20 years of global healthcare marketing
experience. She has built and led marketing teams that have launched medical device products and brands
that became global market leaders and generated over $1B in revenue, while working at Siemens Healthineers
and Varian Medical Systems. Through collaboration with patient advocacy, government advocacy, regulatory,
reimbursement, sales, and product teams she has defined business/pricing models and value propositions to
build successful new product introduction and marketing strategies and oversee the execution. With her
expertise and guidance, we are confident that we will achieve our aims for the NIH-I Corps program.
During the early stages of our company formation, we participated in the National Science Foundation (NSF)
I-Corps program, which was extremely beneficial in helping us understand the epilepsy ecosystem and craft
our initial value proposition. At that time, our team performed 111 interviews of patients, family members,
physicians, payors, pharmaceutical researchers, competitors and potential collaborators. During our previous
NIH I-Corp program we completed over 100 interviews that significantly changed the course of our product and
research. Since the NIH program, we have had an additional Pre-Sub meeting with the FDA, completed our
initial clinical study and pivoted towards a product with better market fit. Based on the interactions with our
partners, and clinical collaborators, we have reformulated our value proposition, pursued additional patents
and refined our regulatory and reimbursement strategy.
The overall goal of participating in the NIH I-Corps is to take our vision and value proposition and add the
granularity which will align our clinical research milestones, regulatory strategy, IP strategy,reimbursement
strategy and fundraising milestones, ultimately leading to successful commercialization strategy which will
position us to obtain venture funding and a Phase II SBIR. We particularly need to do additional risk mitigation
around our revenue model, which focuses on use of existing reimbursement codes and possibly applying for
additional codes, obtaining payment from payers, and ensuring our unit costs and channel partners are aligned
for scaling growth. A structured, healthcare-focused program like that offered by NIH I-Corps would build upon
the tremendous work to date and set the company up for success as we advance our current NIH-funded
initiative to the next phase of development.
Our team is ideally positioned to have maximal benefit from the NIH I-Corps program. Our SBIR Phase I grant
has allowed us to develop and align as a team from a technical perspective. The I-Corps program will enable
us to expand our current technical focus to pre-commercialization topics. We believe that customer discovery
interviews and the lean launchpad system are a timely, structured method to assist our company as we make
this transition from our previous position and have benefited us greatly in the past.
Commercial Potential
Through > 200 customer discovery interviews supported by the NSF + NIH I-Corps program and continued
customer discovery interviews – with epilepsy patients, clinicians, pharmaceutical companies, EEG
manufacturers, and patient advocacy groups – we are confident in the commercialization potential of our
technology. By establishing and growing a partner ecosystem, we are minimizing commercial risks while
expanding our commercial opportunities. While our initial plan was to partner with eye tracking manufacturers,
our new product focuses on using existing smartphone technology reducing many of the hurdles that we
identified during our previous I-Corp. In particular it will significantly reduce our time to market, decrease the
funding requirements, improve user satisfaction and significantly simplify distribution. Lastly, pharmaceutical
companies have expressed strong interest, as shown by financial investments and planned clinical
partnerships to use our solution to assess the efficacy of anticonvulsants in clinical studies. Eysz has received
grant support from Greenwich Biosciences. UCB Pharma, the largest epilepsy drug developer, has also
invested in Eysz.
We are focused on the clinical care market. In the digital health space, commercialization relies heavily on
developing a reimbursement strategy. We plan on leveraging existing CPT codes including behavioral health
codes, remote monitoring codes and nonspecific neurodiagnostic codes. This planning has been complicated
by recent COVID-related changes in telehealth and remote monitoring reimbursement, but we are reassured
that the headwinds towards additional coverage are supporting our reimbursement strategy.
We estimate the overall U.S. market opportunity to be around $3.4 Billion dollars, given the direct costs
associated with epilepsy. With our initial FDA clearance for absence seizures, we expect to capture 5% of the
market ($170M) in 5 years.
Target Customer
For the clinical care market, our end user will be pediatricians and neurologists at a Level 3 + 4 Epilepsy
Center. We understand that purchasing decisions are not solely made by clinicians, but they are influential in
the decision-making process. As part of the I-Corps program, we aim to better understand how products are
recommended for purchasing by neuro service line managers, and pediatric managers, how reimbursement
decisions are made by payors, how best to reach influencers and decision-makers, and the level of integration
with existing workflow required to facilitate adoption.
Clinical Need and Current Alternatives
More than 70 million people worldwide—including ~1% of the U.S. population—suffer from epilepsy, a
debilitating, unpredictable chronic condition in which abnormal electrical activity in the brain produces physical
disturbances including loss of consciousness (LOC) and/or convulsions. Epilepsy is associated with disability,
reduced quality of life, and an elevated risk of comorbidities, including seizure-related injuries; respiratory,
cardiovascular, and neurologic dysfunctions; and psychological conditions such as anxiety and depression.
Outcomes include long-term disability and increased risk of mortality, and epilepsy accounts for 0.5% of the
global burden of disease based on years of life lost (YLL) and years lost to disability (YLD). Globally, the costs
associated with epilepsy are staggering. In the U.S. alone, direct costs have more than doubled in less than a
decade—from $12B to $28B—while outcomes have not improved for almost 3 decades. In addition, epilepsy
accounts for more than 1 million emergency department (ED) visits and over 280,000 hospital admissions
annually in the U.S., with aggregate hospital costs for epilepsy totaling approximately $2.5 billion.
Seizures represent the key symptom of epilepsy and the primary target of epilepsy treatment. Detection of
seizures is the first step in choosing an appropriate treatment regimen, and appropriate anticonvulsants can
decrease seizures by 50%. Unfortunately, current detection technologies are impractical or have limited
effectiveness outside of clinical settings, as described below:
Self-reporting/Observation: As for many other chronic conditions, epilepsy patients are often asked to keep a
seizure diary. Critically, however, patient-reported seizure counts do not provide accurate information.
Studies have shown that during video EEG, caregivers and patients fail to recognize more than 50% of
seizures. In addition, constant seizure observation substantially reduces quality of life due to loss of sleep,
schedule disruption, and anxiety about missing seizure activity. Thus, both patients and clinicians are aware of
the need for a feasible ambulatory technique for the objective detection and registration of seizures.
Outpatient EEG: There have been many attempts to convert the gold standard of EEG plus video observation
into a less burdensome mobile platform. To date, however, video EEG remains expensive, largely limited to
hospital settings, uncomfortable for patients, and associated with a significant delay between seizure activity
and diagnosis. A proposed alternative is ambulatory EEG platforms, which forego the video portion to enable
use at home, but these too have significant limitations. In particular, removal of the video portion of the EEG
significantly reduces EEG sensitivity and specificity. Neurologists are taught not to make decisions based
on EEG alone, severely limiting the utility of video-free outpatient EEG detection methods. Another recent
approach is to remove the role of physicians in EEG interpretation and instead to develop ML-based algorithms
to identify seizures in EEGs in real time, but these are not yet sensitive or specific enough to use without
physician review. Finally, while EEG-based wearables have increased in number and improved in usability and
aesthetics, the challenges associated with the use of EEG as an underlying technology have still not been
addressed.
Non-EEG Devices: Given the limitations of adapting video-based and non-video-based EEG seizure detection
devices, other solutions have been developed that rely on a combination of different detection methods,
including accelerometers, electromyography, infrared motion detectors, or other means to track convulsive
seizures (i.e., generalized tonic-clonic seizures, or GTCs, which make up < 25% of all seizures). These mobile
devices use signals from biometric sources such as limited EEG, heart rate, motion sensors, limb
acceleration/movement, electrodermal activity, muscle activation, and audio/video. However, these solutions
are not comprehensive enough to cover both GTC and non-convulsive seizures, have high
false-positive rates, and/or have clinically unacceptable sensitivity/specificity.
Due to the limitations of current technologies outlined above, there remains a critical need for a more robust
technology that can detect a broader variety of seizures and alert caregivers or healthcare providers to ensure
timely intervention.
Competitive Advantage
Eysz is developing an mHealth app and accompanying algorithms to improve diagnosis and monitoring of
CAE. A standard HV tool that could aid doctors in patient diagnosis and supplement home seizure diaries will
improve CAE diagnosis, management and therapeutic development. Doctors and caregivers currently do not
have an accurate way to identify changes in absence seizure frequency or reliably monitor treatment benefits.
Since clinicians struggle to identify absence seizures, the utilization of the Eysz mHealth tool in PCP offices will
lead to faster, more appropriate referrals. For neurologists, the Eysz tool will help with titrate medicines and
guide the decision to perform a VEEG for seizure freedom. As pharmaceutical studies currently rely on
self-reported seizure counts and >24-hour VEEGs in hospital settings, Eysz would decrease costs and improve
patient access to clinical studies for absence epilepsy. As a more accurate, reproducible method of seizure
monitoring, the app has the potential to transform the diagnosis and management of absence seizures,
improving drug development, medical decision-making, and patient QOL. Eysz intends to first demonstrate the
utility of the mobile seizure monitoring in CAE, then expand into the larger patient population of focal impaired
awareness seizures (FIAS).
Price Estimate
EEG hardware costs $20K–30K per unit, with charges of $500/hour for an outpatient EEG or $2500–5000/day
for inpatient EEG (average hospitalization of 2–3 days). Smartphone technology is ubiquitous and costs are
anticipated to decrease significantly in the coming years. These compatible technologies could potentially be
used for several months/years without losing performance. Existing CPT codes, which could be utilized for the
Eysz solution, reimburse $100–200 per month, making the Eysz solution a highly affordable option compared
to EEG. As part of the I-Corps program, we aim to understand how to price for clinical value when
reimbursement may not be present, understand channel costs, pricing models for fee for service institutions
and fee for value institutions, and scalability of this approach.
4. Project Plan
With our previous clinical study we were able to develop a technically sound product. We pivoted our product
based on extensive customer discovery. This SBIR phase 1 plans to validate our App based solution and
transition our AI based algorithm developed in our previous SBIR. Thus, in this Phase I SBIR, Eysz plans to
obtain data from 45 children with absence seizures and 30 without and to use a combination of traditional
signal processing and ML techniques to refine an algorithm to achieve the high sensitivity required for use as a
seizure monitor. Towards that goal the clinical study is in IRB review. We are confident in our ability to enroll
the necessary patients based on Cincinnati Children’s high patient volume. During this technical phase we
plan on doing extensive work towards our pre-commercialization, with an emphasis on developing channel
partners, regulatory and reimbursement strategies.

Public health relevance
Narrative Childhood absence epilepsy (CAE) is the most common pediatric epilepsy syndrome, affecting 10–17% of all children with epilepsy. Those with CAE often experience significant diagnostic delay and limited monitoring due to the difficulty in detecting absence seizures, which also limits clinical studies of new anti-epileptic drugs in this patient population. An in-clinic diagnostic method would reduce the wait times associated with in-clinic VEEG appointments, potentially reducing time-to-diagnosis and improving access, especially in rural and low-income areas.